Research Track Radiology Residency

The Department of Radiology at the University of Pennsylvania proposes continuation of its innovative T32-
spomsored Research Track Radiology Residency Program with the goal of developing imaging clinician-
scientists. The clinical and scientific importance of biomedical imaging, rapid progress in imaging technology,
and an increasing investment in imaging research create an ongoing and increasing need for imaging-based
clinician scientists to assure translation of these advances into human research and clinical practice. There
continues to be a talented pool of resident applicants to academic radiology residency programs across the US
but only a small fraction of programs equipped to fully train radiology clinician-investigators. The training
program described for this proposal continues the Penn radiology residency track designed for trainees
interested in careers as imaging scientists, leveraging a highly active program in imaging and image-guided
therapy and the large and well-developed research infrastructure within Penn's Radiology Department. The
Program specifically includes 1 year of research training during the 4th year of radiology residency and a
second optional research fellowship year undertaken in the context of an integrated radiology resident
experience that meets the requirement for board certification. In this renewal proposal, we continue to
emphasize the development and application of technology for biomedical imaging and image-guided therapy
apropos to NIBIB training priorities. We leverage the considerable success of our prior and current trainees in
obtaining academic radiology faculty positions, publishing high-impact research papers, and developing
independent research programs and funding, including the first 2 NIH Early Independence Awards ever given
to investigators primarily appointed in a radiology department. Other accomplishments include successful
integration of the research preceptorship year and research undertaken during subsequent fellowship
specialty training in order to assure continuity. Proposed Program innovations for this renewal include (1) a
dedicated spot for Interventional Radiology spurred by increasing research in the field and new training
pathways; (2) increased focus on rapidly advancing areas of imaging research – molecular imaging, imaging
analytics/informatics, and image-guide therapy – with new faculty mentors in these areas; and (3) further
integration of post-residency fellowship training and research to assure continuity from the Program's
dedicated research preceptorship. In summary, we request to continue our highly successful program to train
imaging and image-guided therapy focused clinician-scientists.

Public health relevance
Health-relatedness statement This program proposes continuing the Research Track Radiology Residency Program, which incorporates research training into the clinical radiology residency. This will produce clinician-scientists who can perform high-quality imaging research that is relevant and translatable to patient care.